DATA COORDINATING CENTER FOR SPROUTS AGES 6- AND 7- YEARS ASSESSMENTS AND STUDY CLOSEOUT

The Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD), Division of Intramural Population Health Research (DIPHR) requires data sup ort for the child ages 6- and 7-years assessments for an observational cohort study titled Sprouts: Development of eating behaviors in early childhood. The study is following approximately 200- 250 mother-child dyads from among participants of a DIPHR-funded pregnancy/infancy cohort study. The contractor will monitor and manage data including but not limited to laboratory cognitive and behavioral assessments, eye-tracking, dietary assessment, self-administered questionnaires, biospecimens, clinical data, and anthropometrics. Most data will be collected electronically through the NICHD web-based data collection system called the Clinical Trials Database (CTDB, https://ctdb.nichd.nih.gov/ctdb/). The clinical site will collect dietary intake data using the Nutrition Data System for Research (NDSR) (http://www.ncc.umn.edu/products/). Data collection will be followed by data management, cleaning and analysis, culminating in delivery of the final datasets and documentation.